Core A: Admin Core

CORE A: ADMINISTRATIVE AND RESEARCH SUPPORT
The Administrative and Research Support Core (A) will ensure the general direction and
cohesiveness of the Duke Center for Population Health and Aging (CPHA), which is part of the
Duke University Population Research Institute (DUPRI), organizationally located within the
Provost’s Social Science Research Institute (SSRI). The Center will be led by a Director and
Executive Committee with the support and oversight of an Advisory Committee. The goals of the
Core include fostering communication and collaboration among Center affiliates and promoting
greater communication and collaboration with the broader scientific community to achieve
innovative, high impact research in aging. Core A will provide general administrative support
services and technical and research resources to meet proposed objectives across all Cores,
with the backup support of SSRI staff, facilities and services. Core A is designed to give CPHA
the range and depth of administrative and research resources it needs to motivate and sustain
innovative research and data collection described in Cores B, C and D. Research services
provided by experienced staff in computation and data management and research development
will assist teams of investigators to achieve their aims and to communicate research findings to
the research community in aging.